The Study of Human Sulfuryl-Transfer Biology

During the last half century the scientific community has catalogued hundreds of signaling small molecules
that are potently regulated via sulfonation — pheromones, drugs, toxins, steroid and peptide hormones,
nuclear- and dopamine-receptor ligands… . Controlling sulfonation of specific metabolites in vivo would allow
experimentalists to probe and control sulfur biology with unprecedented precision. Our recent structure/function
studies resulted in a robust strategy for preventing sulfonation of a single compound in vivo without altering its
receptor interactions or inhibiting sulfotransferases (SULTs). Numerous diseases have been causally linked to
sulfonation of individual metabolites. Now, for the first time, we can hope to control these reactions. We
recently applied the strategy to an estrogen-receptor agonist and increased its in vivo efficacy ~10,000-fold.
We will create, and test in vivo, sulfonation-resistant derivatives of three compounds (two FDA-approved drugs
and one endogenous metabolite) with the goal of improving our ability to prevent certain Parkinson's
symptoms, control contraception, and regulate thyroid-hormone metabolism.
The subject of SULT small-molecule allostery is in its infancy. Eleven of the thirteen human SULT isoforms,
each of which operates in separate metabolic domain, harbor one or more allosteric sites. The metabolite-
allosteres that bind these sites, and hence pathways linked to the isoforms, remain unknown. We are isolating
biomedically relevant, isozyme specific SULT allosteres from small-molecule human-tissue and microbiota
libraries, bioactive screening libraries, and in-silico metabolite libraries. We have recently discovered that
tetrahydrobiopterin (THB), an essential cofactor in catecholamine neurotransmitter biosynthesis, is a potent,
highly specific allosteric inhibitor of SULT1A3, which inactivates neurotransmitters. The sulfonation-dependent
regulation of neurotransmitter activity in human brain recommends the THB pocket as a novel
neuropharmacological target. We have developed methods that allow SULT ligand-binding site structures to be
determined in a matter of days from a ligand's 1D NMR spectrum. We are using these structures, in
conjunction with MD-modelling and protein-function studies, to understand the molecular basis of allostere
function with the goal of creating compounds that can inhibit, activate and change the substrate specificities of
individual SULT isoforms. Using these methods, we have created the first “man-made” SULT allosteric inhibitor
— a potent, highly selective SULT1A3 inhibitor.
The constant undercurrent of protein-function studies in this laboratory is a well-spring of discovery. We are
now revealing that promiscuous, half-site enzymes (e.g., SULTs) conformationally couple the energetics of
their disparate reactions to one another — a finding whose implications transcend sulfuryl-transfer metabolism.
In addition, we are creating cutting-edge models of SULT allostery and catalysis, and we intend to apply our
expertise to the UDP-glucosyltransferases — the other major phase II enzyme system.

Public health relevance
Relevance Human cytosolic sulfotransferases (SULTs) have been causally linked to numerous human diseases; yet, mankind has no means of controlling these enzymes in vivo. The proposed studies will create unprecedented molecular descriptions of SULTs and use them to create molecular tools that can control SULT activity in living systems with exquisite precision. The work is expected lead to new therapeutic avenues and enhance SULT-biology research capabilities.